Clinical Research and Community Engagement Core

PROJECT SUMMARY/ABSTRACT (Clinical Research and Community Engagement Core)
The Tulane COBRE for Clinical and Translational Research in Cardiometabolic Diseases (Phase 1) has
successfully supported Tulane University's efforts to increase the quality and quantity of clinical and
translational research in cardiometabolic diseases. The Clinical Research Core played a central role in the
success of COBRE Phase 1, which included seven Research Project Leaders (RPLs) and Pilot Project
Leaders (PPLs) who received one or more research grants from NIH and NSF and 310 peer-reviewed
scientific articles published by COBRE investigators. This COBRE Phase 2 application aims to further develop
and strengthen the clinical and translational research infrastructure at Tulane University and to continuously
expand and support a critical mass of investigators with expertise in clinical and translational research in
cardiometabolic diseases. In Phase 2, the Clinical Research Core will be expanded into the Clinical Research
and Community Engagement (CRCE) Core and the Bioinformatics and Biostatistics Core. The CRCE Core will
continue to support RPLs, PPLs, other COBRE investigators, and collaborators through our research clinics
and biochemical laboratories and will expand efforts to strengthen and broaden capacity for community
engagement across the translational research spectrum. The overall objectives of the CRCE Core are two-fold:
to enhance and expand an effective and robust infrastructure for clinical and translational research, including
research clinics, clinical and biochemical laboratories, and community engagement at Tulane University, and to
facilitate and support RPLs, PPLs, other COBRE investigators, and collaborators in the planning and conduct
of clinical research. To achieve these objectives, the specific aims are: 1) provide clinical research facilities and
staff for study protocol development, regulatory support, participant recruitment, intervention conduct, and data
collection for RPLs, PPLs, other COBRE investigators, and collaborators to implement their individual research
projects, 2) provide clinical and biochemical laboratory support for the collection, processing, analysis, and
storage of study specimens, 3) increase capacity for community and stakeholder engagement across the
spectrum of translational research in cardiometabolic diseases to enhance study recruitment, retention, and
dissemination and translation of study findings, and 4) develop a plan to ensure the long-term sustainability of
Core operations. The CRCE Core is critically important for the proposed COBRE Phase 2 program. All four
proposed individual Research Projects will utilize the clinical research space and staff and biochemical
laboratories. In addition, community engagement support is available to RPLs, PPLs, other COBRE
investigators, and collaborators. The CRCE Core will play a central role in assisting RPLs and PPLs with their
Research Projects and their transition into independent investigators. The Core will also play an important role
in establishing and maintaining a nationally and internationally recognized clinical and translational research
program in the etiology, prevention, diagnosis, and treatment of cardiometabolic diseases at Tulane University.